Aquisition of a confocal cryo-light microscope for correlative light and electron microscopy

Project Summary:
The Principle Investigators (PIs) are seeking an administrative supplement to obtain a confocal
cryo-correlative light/electron microscope (cryo-CLEM) for their research project, "RNA Penetrations into
Bacteria" (R01GM141659). The study aims to understand the molecular mechanisms underlying the interaction
between single-stranded RNA bacteriophages (ssRNA phages) and their host bacteria, with a focus on PP7
and AP205 phages, which infect Pseudomonas aeruginosa and Acinetobacter spp., respectively. The PIs hope
to use this information to develop new approaches to combat multi-drug-resistant bacterial infections by
mitigating the virulence of these pathogens.
The team plans to investigate the in situ phage packaging process, the phage adsorption pathway, and
the RNA entry/pili detachment events using multi-scale imaging tools, including fluorescence microscopy and
cryo-electron microscopy/tomography (cryo-EM/ET). They have already obtained high-resolution cryo-EM
structures of both phage PP7 and AP205 alone or in complex with the host receptors, the type IV pili, and have
characterized molecular events associated with pili detachment upon phage infection.
The PIs request a confocal cryo-CLEM, which would enhance their imaging capabilities and benefit
their project in two main ways. Firstly, a cryo-CLEM can provide both high-resolution imaging and real-time
observation capabilities, bridging the gap between traditional light microscopy and cryo-EM/ET. Secondly, the
team aims to test their findings in the context of Pseudomonas biofilms, and confocal fluorescence microscopy
is essential for understanding the spatial organization of bacterial cells and phages during infection.
Drs. Zhang and Zeng, the PIs, have collaborated with Nikon and Linkam to create a cryo-CLEM setup
tailored to their project. The instrument will be located in Dr. Zhang's newly renovated lab, which is right next to
Dr. Zeng's lab in the Department of Biochemistry and Biophysics building. Dr. Zeng, who has over 15 years of
experience with fluorescence light microscopy, will supervise the operation and maintenance of the confocal
cryo-CLEM in coordination with Dr. Zhang. This instrument will not only support the PIs’ current research
project but also have long-term value for future research in the Texas A&M community.

Public health relevance
Project Narrative: The proposal seeks to advance the PIs’ research on RNA phage infection processes by acquiring a state-of-the-art confocal cryo-correlative light/electron microscope (cryo-CLEM) that offers high-resolution 3D imaging and real-time observation capabilities. This cryo-CLEM will complement PIs’ existing high-end cryo-electron microscopy, allowing them to visualize RNA phage infections in cells and biofilms with unprecedented detail. The instrument will not only support the PIs’ current research project but also have long-term value for future research in the TAMU community.